Endothelin 1 in iron handling in sickle cell disease

Abstract: Sickle cell disease (SCD) is an inherited chronic hemolytic anemia characterized by vaso-occlusive
episodes and end organ damage. Up to 80% of patients with SCD will develop chronic kidney disease (CKD),
with 30% mortality ascribed to kidney failure. This devastating health outcome exists because there are
numerous gaps in our understanding of complex mechanisms underlying SCD nephropathy. In patients
and murine SCD, an increased renal iron deposition occurs primarily in proximal tubules (PT), and correlates
with albuminuria, an early marker of CKD. Kidney-specific etiology of iron accumulation is purely a consequence
of intravascular hemolysis, not chronic blood transfusion. Current interventional strategies are limited to the
chelation of transfusion-mediated iron overload only. Classic iron chelators are nephrotoxic, and there are no
available strategies targeting kidney iron overload, thus there is an unmet need for novel iron overload-modifying
reno-protective strategies. However, molecular mechanisms of renal-specific iron handling remain to be
elucidated. My preliminary studies indicate that ET-1 promotes PT iron accumulation. I observed a strong
positive correlation between plasma ET-1 levels and renal iron accumulation in both mice and patients with SCD.
Furthermore, selective ETA receptor antagonist reduces iron deposition in the kidney, at the same time increasing
urinary iron excretion and serum iron levels in SCD mice. Third, my in vitro data show that ET-1 directly increases
the expression of transferrin-1 receptor (iron uptake transporter) and decreases the expression of ferroportin-1
(FPN-1, iron exporter) in mouse PT cells. Together, these observations point to ET-1/ETA signaling as a novel
regulator of renal iron handling in SCD. Based on these novel preliminary findings, we hypothesize that ET-
1/ETA activation promotes renal iron overload via direct increase in heme/iron uptake and/or inhibition
of iron export in SCD. Using primary mouse and human PT cells, we will determine whether ET-1/ETA receptor
activation increases heme/iron uptake via direct and/or HIF-1a-mediated activation of NF-kB signaling pathway.
Using novel humanized SCD mice lacking PT ETA expression, we will determine the effect of ETA receptors
deletion on renal iron burden and kidney health. Second, we will define specific ET-1/ETA-dependent control of
FPN-1 and iron export in vitro, and in vivo mechanisms contributing to ETA-mediated renal iron recycling using
acute hemolysis model. Lastly, we will determine the effect of ETA receptor antagonism on iron recycling and/or
urinary excretion in SCD patients. We aim to unveil these molecular mechanisms with the following aims:
Specific Aim 1: Determine the mechanism(s) by which ET-1/ETA signaling promotes iron uptake by PT and its
subsequent contribution to SCD nephropathy.
Specific Aim 2: Determine the mechanism(s) by which ET-1/ETA signaling reduces PT iron export,
subsequently leading to iron accumulation in SCD.
Specific Aim 3: Assess the relationship between renal iron handling and ETA antagonism in SCD patients.

Public health relevance
Project Narrative Sickle cell disease, an inherited chronic hemolytic anemia, is associated with iron toxicity and increased mortality from prolonged iron overload. Iron chelation, a primary treatment for transfusion but not hemolysis driven iron overload, presents with low tolerance and nephrotoxicity. This project will examine novel mechanism(s) controlling kidney-specific iron handling in vitro and in mouse models in order to identify novel therapeutic approaches to improve harmful iron overload burden in sickle cell disease.